ALCOHOL TREATMENT UNDER MANAGED CARE PLANS--ROLE OF HMO

The main objective of this study is to understand how alcohol services are provided in health maintenance organization (HMOs) and to model decisions to provide these services internally or through a carve-out. The specific aims for this study include the following: 1. Describe the provision of alcohol services in HMOs in terms of several factors, including overall plan and market characteristics, and characteristics of the alcohol services themselves in terms of contracting with vendors, treatment approaches, payment methods and risk sharing, utilization management, provider selection, entry into treatment, benefit. Model why some HMOs provide alcohol services internally within the plan and other HMOs choose to carve-out alcohol services to be delivered by a specialty managed behavioral health care organization. To examine questions related to these two specific aims, we will conduct a telephone survey 160 HMOs in 30 market areas. We will collaborate with the longitudinal, nationally representative Community Tracking Study (CTS) conducted by the Center for Studying Health System Change. In 30 of the same market areas as CTS and in the year following their health plan survey, we will survey a sample of the same HMOs (stratified into two groups according to how they provide alcohol services. Integrated or carve-out), regarding the provision of alcohol treatment services.